PHYSICAL &MENTAL EFFECTS OF FEEDING YOUR BABY

Study will examine how breast-feeding and bottle-feeding a baby affects the nervous system of the mother. Mothers will at one time breast feed then at another time, bottle feed their infant while instruments for non-invasive psychophysiological measures of blood pressure and heart rate. The degree of variability in these measures will be used as an indices of sympathetic and parasympathetic modulaltion of the cardiovascular system.